Mechanisms of cAMP-dependent regulation of melanosome pH

SUMMARY
Melanosome pH controls pigmentation and affects skin cancer risk; however, the signaling pathways that affect
this important pigment mechanism are poorly understood. The Melanocortin 1 Receptor (MC1R), through
transmembrane adenylyl cyclase (tmAC)-defined cAMP signaling pathways, has an important role in
pigmentation, and affects skin cancer risk by activating the expression of key pigment synthesizing enzymes.
But whether MC1R signaling affects melanosome pH has remained unclear. We recently identified a new
cAMP signaling pathway in melanocytes, defined by the soluble adenylyl cyclase (sAC), that regulates
melanosome pH. Whereas elevation of tmAC-dependent cAMP increases eumelanin by upregulating key
pigment enzymes (e.g., tyrosinase), a reduction in sAC-dependent cAMP also increases eumelanin by
inducing the alkalization of melanosome pH and enhancing tyrosinase activity. Thus, our overarching
hypothesis is that sAC and tmACs regulate distinct cAMP signaling cascades in melanocytes and function in
concert to control pigmentation. What remains unclear are the upstream and downstream mechanisms that
control sAC-dependent regulation of melanosome pH and pigmentation. In our first Aim, we will use human
primary melanocytes expressing either wild type MC1R or MC1R polymorphisms along with Mc1re mouse
melanocytes and a novel Mc1re (e/e) conditional sAC knockout mouse to determine the interplay between
MC1R signaling and sAC-dependent control of melanosome pH and pigmentation. In our first Aim, we will also
assess whether bicarbonate, a known stimulator of sAC that has been linked to melanin synthesis, affects
melanosome pH and pigmentation in human and mouse melanocytes in a sAC-dependent manner. In Aim 2,
we will determine how sAC regulates melanosome pH and pigmentation. Our preliminary data suggests that
sAC activates the cAMP effector protein exchange protein activated by cAMP (EPAC), which then stimulates
the melanosome ion channel two-pore channel 2 (TPC2). Using genetic and pharmacological methods in
mouse and human melanocytes, we will establish which EPAC isoforms and melanosome channels are
required for sAC-dependent control of melanosome pH. Finally, our preliminary data suggest that sAC
inhibition rescues the defective melanosome pH and tyrosinase activity in Oca2 deleted mouse melanocytes
both in vitro and in mice. Thus, pharmacological sAC inhibitors are potential therapeutics for oculocutaneous
albinism type 2. We will further explore this therapeutic possibility with a new conditional sAC knockout Oca2-/-
(p/p) mouse model. Overall, the experiments in this proposal will systemically examine the cAMP dependent
signaling cascades that regulate melanosome pH and pigmentation. The proposed studies will establish new
models that will overcome limitations in our investigation of cAMP signaling in pigmentation, will provide
greater insight into the cAMP-dependent mechanisms that control melanosome pH, and may lead to new
therapeutics for diseases of pigmentation.

Public health relevance
PROJECT NARRATIVE Cyclic AMP (cAMP) signaling is central for skin pigmentation and has a significant impact on skin cancer and melanoma risk. Whereas the canonical melanocyte cAMP cascade controls pigmentation by activating pigment gene expression via established mechanisms, we recently identified a second cAMP cascade that is distinct from the canonical pathway and controls pigmentation by regulating melanosome pH. Using novel in vitro and in vivo approaches for the investigation of cAMP, we will identify the upstream and downstream mechanisms of cAMP-dependent regulation of melanosome pH.